Photo-Fragmentation Methods for Single-Molecule Protein Sequencing by Nanopore Mass Spectrometry

PROJECT SUMMARY
A single molecule protein sequencing technology would revolutionize our ability to study biology
and to diagnose and treat disease. Mass spectrometry has a unique ability to identify amino acids
by their mass-to-charge ratios, but current instruments fall well short of the single-molecule
sensitivity limit. On the other hand, nanopore sensors operate on single molecules and naturally
preserve the sequential ordering of a biopolymer, but they cannot discriminate the different amino
acids. We envision a protein sequencing technology in which a new, nanopore-based ion source
addresses the current shortcomings of mass spectrometry. The basic idea to first denature the
protein, then drive it through a nanoscale hole that compels its constituent amino acids to pass in
sequential order, then break the polymer into separate monomers by photo-fragmentation, and
finally deliver those amino acids into a mass spectrometer where they can be identified by their
mass-to-charge ratios.
We recently demonstrated a nanopore ion source that can deliver desolvated amino acid ions
directly into the high vacuum part of a mass spectrometer from aqueous solution. The nanopore
ion source thus circumvents the sample loss mechanisms inherent to conventional electrospray
ionization (ESI), where charged droplets are sprayed into a background gas that scatters ions
and degrades their transmission. Furthermore, we recently designed a mass spectrometer that
exhibits two new capabilities we need for sequencing: 1) an ability to simultaneously measure
ions with different masses and 2) an ability to tag each ion with an arrival time with sub-100 ns
temporal resolution. The main unproven part of our sequencing strategy is a method for
transforming peptides (i.e., polymers) into separate amino acids inside the nanopore ion source.
This project will investigate the feasibility of fragmenting peptides with light within a nanopore ion
source. We seek to fragment peptides into separate but intact amino acids. Ultraviolet light with
a wavelength near 200 nm is promising for this purpose because it is selectively absorbed by
peptide bonds and because a single photon carries enough energy to induce scission of that
bond. Through the Aims of this project, we will measure the speed and selectivity with which
different wavelengths of light cleave the peptide bond, and we will apply that knowledge to
demonstrate peptide fragmentation within our nanopore ion source.

Public health relevance
PROJECT NARRATIVE A single molecule protein sequencing technology would have a transformative impact on the study of proteomics and on the development of diagnostics and treatments for disease. We envision sequencing a single protein by fragmenting it into its constituent amino acids, sequentially delivering the amino acids into a mass spectrometer in an ionized state, and then identifying them by their charge-to-mass ratios. This project will establish the feasibility of using ultraviolet light to fragment peptides into amino acids in that scheme.